Multicomponent Therapy for Age-related Skin Stem Cell Deficiency

SUMMARY
Chronic ulcers, defined as wounds that fail to heal within a three-month period, are associated with age-related
dysfunction in skin stem cells that not only has potential to blunt tissue repair, but also accounts for skin fragility,
atrophy, and the "aging phenotype" that itself has clinical as well as psychosocial implications. Non-healing
ulcers in aging individuals represent a multibillion dollar burden in the United States and to society globally, both
through utilization of health care resources as well as through reduction in productivity. Nonetheless, it is
recognized that "the basic biology and the influence of age-associated changes on wound healing are poorly
understood, and there are numerous research questions still to be answered". To address this important issue,
we have 1) assembled a highly collaborative and multidisciplinary team of investigators with established track
records in skin pathology, regenerative and stem cell biology, wound healing, bioinformatics, and the
pathobiology of aging; 2) leveraged the resources of seven Harvard Institutions to develop a unified and state-
of-the-art approach to decipher the role skin stem cell deficiency in age-related defective wound healing; and 3)
generated data-based hypotheses and identified inter-project synergies that will maximize productivity and
translational focus. Our fundamental hypothesis is that identification and interrogation of three major, inter-
related, and therapeutically targetable/reprogrammable pathways relevant to age-related skin stem cell
dysfunction, a) metabolic, b) epigenetic, and c) membrane transporter/receptor, will pave the way for
combinatorial (multicomponent) therapies necessary for more robust healing and regenerative responses to skin
injury. We will pursue this goal through six strategies that have been developed by the key personnel of this
PPG: 1) discovery of biomarkers for epidermal and dermal stem cell identification and manipulation; 2)
determination of metabolic regulators required for epidermal progenitor activity and maintenance; 3) identification
of novel epigenetic pathways that govern skin stem cell function and vitality; 4) development and evaluation of
unique murine models that permit study of human wound healing in vivo; 5) deployment of lineage tracking
technologies that facilitate detection of experimentally-manipulated stem cell fate in healing wounds; and 6)
generation of new animal strains and for epigenomic induction of premature aging and methods for genomic
restoration of stem cell youth and pluripotency. Our overall aims seek to answer the following questions: 1) How
can one map the key metabolomic, epigenetic, and cell receptor stem cell pathways that drive age-related wound
healing dysfunction?; 2) What are the therapeutically-accessible nodes for stem cell-directed multicomponent
combinatorial targeting within these pathways?; and 3) What are the agents that likely will affect restoration of
robust and regenerative stem cell-driven responses to wound healing and support physiologic cutaneous
maintenance and health? Success in this endeavor could be transformative in understanding how aged stem
cells may be restored to functional vigor implicit to normal tissue integrity and regenerative potential.

Public health relevance
NARRATIVE Chronic non-healing skin ulcers are a source of considerable suffering worldwide, particularly in rapidly growing aging populations. Why skin becomes fragile and heals poorly as we age remains unclear, although current research indicates that a major reason may reside in defective “stem cells” in skin that normally fuel its renewal and regeneration in order to maintain healthful and youthful function and appearance. Our findings indicate that stem cell pathways involving cell metabolism, DNA regulation, and cell-cell communication may underlie defective wound healing. Our research proposal is designed to explore this hypothesis with the overarching goal of developing new approaches that will pave the way for stem cell-directed combined therapies that will accelerate wound healing and potentially even repair and restore age-damaged skin.